Novel mechanisms and therapeutics for Tyrosine Kinase Inhibitor-induced Cardiotoxicity

PROJECT ABSTRACT
Tyrosine kinase inhibitors (TKIs) have become a cornerstone in treating broad spectrum cancers with remarkable
improvement in cancer-related outcomes. However, their use has been limited by significant cardiotoxicity, most
notably left ventricular dysfunction. Recently, there have been increasing reports linking cardiac dysfunction to
osimertinib, a third generation TKI targeting activating mutation of epidermal growth factor receptor (EGFR) in
lung cancer. Yet, the mechanism underlying osimertinib-induced cardiac dysfunction (OICD) remains poorly
understood and presently there is no specific therapy to prevent or rescue OICD. Therefore, the overarching
goal of this proposal is to investigate the molecular mechanism of OICD and explore potential therapeutic targets.
To achieve this goal, we first established a novel mouse model for OICD. Through single nucleus-RNA
sequencing of osimertinib-treated mouse hearts, we identified a significant downregulation of myosin light chain
kinase 3 (MYLK3), which is responsible for phosphorylation of myosin light chain 2 (MYL2) and promoting the
interaction between cardiac myosin and actin to initiate contraction. When human induced pluripotent stem cell-
derived cardiomyocytes (iPSC-CM) were subjected to osimertinib, we observed profound contractile dysfunction
along with markedly decreased MYLK levels and significantly reduced MYL2 phosphorylation. This formulates
our central hypothesis that EGFR TKI osimertinib causes contractile dysfunction by interfering actin-
myosin interaction through the suppression of MYLK3 and disrupted MYL2 phosphorylation. To test this
hypothesis, we will first examine the association between MYLK3 and OICD using control iPSC-CM lines,
performing comprehensive molecular and functional analyses. To establish the causal link between MYLK3 and
OICD, we will assess whether overexpressing MYLK3 in osimertinib-treated iPSC-CMs as well as in the OICD
mouse model would sufficiently prevent the observed cardiotoxicity (Aim 1). Next, we will investigate whether
variation in baseline levels of MYLK3 and MYLK-related pathways contribute to differential susceptibility to OICD
by leveraging pooled iPSC lines derived from 20 patients with and without OICD (Aim 2). Finally, we will explore
myosin activators as a therapeutic strategy to prevent OICD while preserving anti-cancer activity of osimertinib
(Aim 3). This proposal addresses important knowledge gaps in cardiovascular complications of osimertinib. The
results of this proposal hold immediate translational potential, ultimately improving the care of lung cancer
patients suffering from cardiovascular complications.

Public health relevance
PROJECT NARRATIVE The use of tyrosine kinase inhibitors (TKIs) has been associated with significant cardiac dysfunction, which poses a significant risk to both cardiovascular and cancer-related outcomes; in particular, there is a growing body of evidence reporting cardiac dysfunction related to osimertinib, a third generation TKI primarily used in lung cancer. To gain a better understanding of these complications, we aim to investigate molecular mechanisms of osimertinib-induced cardiac dysfunction and explore myosin activators as therapeutic interventions, by leveraging both mouse and human induced pluripotent stem cell models. Given the increasing use of osimertinib in the treatment of lung cancer, the findings of this study will have a rapid clinical impact on the survival and quality of life of lung cancer patients.